Common Regulatory Pathways for the Genesis of Lysosome-Related Organelles and Dynamics of Microtubules during Development

PROJECT SUMMARY
Lysosome-Related Organelles (LROs) contain both lysosomal proteins and cell-type specific proteins
in an acidic lumen. They are enlarged in Chediak-Higashi Syndrome (CHS) patients resulting from
either excessive fusion or inhibition of their fission. The mutated gene in CHS encodes the lysosomal
trafficking regulator (LYST) protein, whose function is poorly understood. Defects in microtubule
behavior and centrosome behavior are seen at the immunological synapse of CHS patients but whether
microtubule nucleation is affected directly in CHS cells is controversial.
To determine LYST's function in LROs and clarify its requirements at microtubules, we will use a
Drosophila model in which mutants of the LYST counterpart, encoded by the mauve (mv) gene, show
enlarged LROs (yolk granules) and microtubule defects in mitosis and in maintaining nuclei at the
correct position in the embryo. Mauve co-immunoprecipitates from Drosophila embryos with factors
involved in maturation of endosomes; a factor enabling dissociation of the SNARE complex from
mature vesicles; Dynein/Dynactin, which have roles in vesicle trafficking and at microtubules; and
several centrosome-associated molecules. Thus, this stage of Drosophila development is highly
amenable to study the role of LYST/Mauve in the biogenesis of LROs and at microtubules and
centrosomes.
To establish the role of the Mauve/LYST complex in regulating LRO size and trafficking, we will follow yolk
granule biogenesis in wild-type and mv-mutant females; determine the effects of constitutively active and
dominant-negative forms of the enodcytotic regulators Rab5, Rab7 and NSF1. To discover the role of
Mauve/LYST complex in regulating microtubule dynamics, we will determine microtubule defects in mv-
derived embryos and establish the genetic interactions between mv and genes for microtubule associated
proteins with which it associates and physical interactions between these gene products. By determining
how Mauve directs the centrosomal association of Minispindles protein; how together with Rab5 and Dynein,
it promotes accumulation of microtubule associated proteins at the centrosome; and how Mauve's partner
proteins participate in recruitment of microtubule organizing molecules at centrosomes we will uncover how
vesicle trafficking associated proteins can participate in promoting centrosomal maturation.
We anticipate that this will define the dual role of Mauve/LYST in regulating vesicle fission/fusion and
in the trafficking of proteins important for microtubule nucleation and centrosome maturation. We
anticipate our findings will translate to human cells where they will have potential to unlock doors for the
development of therapeutic agents to treat the immunological defects of CHS patients.

Public health relevance
PROJECT NARRATIVE Chediak-Higashi Syndrome (CHS) patients show enlarged lysosome-related organelles (LROs) resulting from either excessive fusion or inhibited fission of vesicles together with defects in microtubule and centrosome behavior at the immunological synapse. LRO biogenesis is highly conserved in Drosophila, allowing us to exploit its genetic and molecular cell biological advantages to study both vesicle trafficking and microtubule and centrosome behavior in the oocyte and embryo. This will illuminate the controversial role of the protein encoded by the gene mutated in CHS not only in the LRO, but importantly also in centrosome and microtubule behavior and will thereby unlock possibilities for developing drugs to treat CHS patients.